Molecular interplay of HIV Tat, cocaine, and cART in microglial pyroptosis: Role of NLRP3 inflammasome

Abstract:
Despite the advent of combination antiretroviral therapy (cART), HIV-associated neurocognitive disorders (or
NeuroHIV) remain prevalent, affecting 30-50% of patients and presenting persistent challenges in managing
neurological complications. Glial cell dysregulation, particularly microglia and astrocytes, drives chronic
neuroinflammation in the central nervous system (CNS), exacerbated by HIV proteins such as the Transactivator
of Transcription (Tat). While previous research has implicated inflammasomes, notably the NLRP3
inflammasome, and toll-like receptors (TLRs) in mediating neuroinflammation, the precise mechanisms by which
HIV, cART, and substances like cocaine modulate inflammasome activation and subsequent neuroinflammatory
responses remain poorly understood. Also, pyroptosis, a highly inflammatory form of programmed cell death,
emerges as crucial in inflammatory diseases, including NeuroHIV. Characterized by membrane pore formation
and the release of proinflammatory cytokines like interleukin-1β (IL-1β) and IL-18, pyroptosis exacerbates
inflammation and tissue damage. However, the link between inflammasome-mediated pyroptosis and microglial
activation in the context of HIV Tat, cocaine, and cART, contributing to neuroinflammation in NeuroHIV, remains
elusive and forms the crux of this proposal. This proposed study aims to address these critical knowledge gaps
by elucidating the molecular mechanisms underlying the interplay between HIV Tat, cocaine, and cART in
activating NLRP3 inflammasome signaling pathways, leading to pyroptosis and microglial activation. We
hypothesize that these factors collectively contribute to microglial activation and exacerbate neuroinflammation
through distinct regulatory mechanisms called microglial pyroptosis. This hypothesis will be tested with two
specific aims: 1. determining the molecular mechanism(s) underlying NLRP3-mediated pyroptosis in microglia
exposed to HIV Tat, cocaine, and cART in vitro; 2. validating the combined effects of HIV Tat, cocaine, and cART
on NLRP3-mediated pyroptosis and microglial activation in vivo and isolated ex vivo adult microglia. Archival
macaque brain tissues will also be utilized to validate the microglial pyroptosis and neuroinflammation. This
comprehensive investigation into the molecular mechanisms of microglial pyroptosis and neuroinflammation
induced by HIV Tat, cocaine, and cART holds significant promise for developing novel therapeutic strategies to
alleviate neuroinflammatory responses in NeuroHIV and substance abuse disorders. Furthermore, the
identification of these pathways may uncover new drug targets for the treatment of other neuroinflammatory
diseases, underscoring the broader implications of this research.

Public health relevance
Narrative: This R01 proposal aims to investigate the molecular mechanisms underlying neuroinflammation in NeuroHIV, with a focus on the role of HIV proteins, antiretroviral drugs, and cocaine in modulating inflammasome-mediated microglial pyroptosis. Through elucidating these mechanisms, our goal is to identify potential therapeutic targets for alleviating neuroinflammatory responses and reducing neurological complications in individuals living with NeuroHIV and cocaine use disorders. This proposed research will offer critical insights into the interplay between HIV infection, substance abuse, and neuroinflammation, ultimately advancing our understanding of NeuroHIV pathogenesis and guiding the development of targeted interventions.